Sex and circadian influences on olfactory behavior and neurophysiology

Project Summary
A growing scientific literature concerning the influence of olfaction on cognitive health shows that olfactory
dysfunction is involved in a myriad of diseases, including depression and dementia. Smell deficits are often the first
symptom of Alzheimer’s Disease and other types of dementia. Many of these diseases exhibit sex differences in incidence
and/or clinical presentation along with striking time-of-day dependent changes in symptom severity. Therefore, how
biological factors (sex) and environmental cues (light, time-of-day information) affect olfactory system function will
inform understanding of cognitive health. Despite mandates to include sexes equally in biomedical research, few studies
address sex differences in primary olfactory function relevant to non-sexual odors. Likewise, circadian function is largely
ignored in olfactory research. The majority of behavioral testing occurs during the light phase, even though lab rodents are
typically nocturnal, and behavior and physiology vary strikingly across the day.
This proposed work will examine cognitive and physiological factors underlying sex differences in olfactory
behavior and interactions between time of day and sex in odor processing in rats. Preliminary data indicate that female
rats sample odors as much as 40% longer than males when they are rewarded to learn an odor discrimination task, but this
sex difference is reversed when rats learn new odors without any reinforcement, suggesting that odor sampling is not
simply dictated by sex, but instead the sex difference depends on what is being learned. Moreover, these sex differences in
behavioral strategy fluctuated based on the time of day. Preliminary neurophysiological recordings show that females
produce lower amplitude fast cortical oscillations than males when sniffing odors, and that female and male brains show
different olfactory-hippocampal network configurations when performing an odor discrimination task. Here we will test
the hypotheses (1) that females and males utilize distinct behavioral and neurophysiological mechanisms to solve
olfactory learning tasks, and (2) that olfactory cognitive skills vary over the circadian cycle. Aim 1 examines sex
differences in olfactory behavior and neurophysiology, using odor habituation and two operant associative odor
discrimination tasks; these studies will identify interactions among sex, task difficulty, and the cognitive structure of the
task itself. Studies will also define the role of circulating sex hormones in driving sex differences. Aim 2 interrogates how
circadian time affects olfactory cognition; these studies will characterize how behavior and neurophysiology vary when
rats are tested across multiple phases of the light and dark cycle. Male and female rats will be included in equal numbers
in all experiments. To permit analysis of neural signals from olfactory and hippocampal regions, electrophysiology will be
performed in a smaller group of rats as they learn odors and perform tasks.
Sex and time-of-day currently contribute an unknown degree of variance to research in olfactory neuroscience.
These innovative experiments will quantify these sources of variance and thereby enhance rigor and reproducibility in
research on odor perception and olfactory neurophysiology. The outcomes will inform basic questions about how sex and
time affect the brain and will serve as a foundation for future practices in olfactory neuroscience research.

Public health relevance
Project Narrative The olfactory system is implicated in diseases that produce dementia, many of which exhibit significant sex differences and vary in their clinical presentation over the course of the day. Most olfaction research has focused on males and is conducted during the daytime, neglecting how biological sex and circadian rhythms affect olfactory perception and cognition. This study addresses previously unreported sex and circadian effects on behavior and central nervous system function associated with the sense of smell.